Adaptation of a Digital Group-Based Intervention to Reduce Drug Use and Increase Contraceptive Use among Reproductive-Aged Women Involved in Criminal Justice Systems

PROJECT SUMMARY/ABSTRACT. The purpose of this K01 Award is to provide the candidate, Dr. Melissa N.
Slavin, at Columbia University School of Social Work, with the training needed to become an independent
substance use investigator in digital intervention science with a focus on sexual and reproductive health (SRH)
issues among vulnerable women, particularly women involved in criminal justice systems (WICJ). Dr. Slavin
proposes to adapt and determine the feasibility and acceptability of a digital intervention, which will include
facilitated group-based treatment via videoconference, and digital interactive activities, for reproductive-aged
women with a recent history of incarceration or community supervision. This intervention aims to reduce illicit
drug use and increase all forms of contraceptive use among women with substance use disorders (SUDs) and
unmet contraceptive needs (i.e., fecund, sexually active, and report not wanting more children or wanting to
delay the next child but are not using any method of contraception). WICJ, the majority of whom are reproductive-
aged, have high rates of SUDs and unmet contraceptive needs, influenced by synergistic individual-,
interpersonal-, and community-level risk factors. Unmet contraceptive needs result in unintended pregnancies
(UPs) among WICJ with SUDs, and increased rates of morbidity and mortality among women and their offspring.
Extant interventions among WICJ who use drugs often focus on sexually transmitted infections (STIs), including
HIV, while leaving out UPs. Among reproductive-aged women in general, digital interventions are effective at
reducing drug use and increasing contraceptive use, and can increase reliability of implementation, accessibility,
and personalization. Digital HIV-prevention interventions for WICJ who use drugs can provide a key platform to
address UPs among reproductive-aged women. Multimedia WORTH, an evidence-based HIV-prevention
intervention uses in-person groups and digital interactive activities to address risk factors among WICJ who use
drugs and is effective at increasing condom use. Dr. Slavin will adapt Multimedia WORTH for reproductive-aged
WICJ with SUDs and unmet contraceptive needs, using a digital intervention (facilitated group-based treatment
via videoconference, and self-paced activities) through 3 research aims (RAs): RA1: Identify modifiable
determinants of drug and contraceptive use among reproductive-aged WICJ via qualitative interviews; RA2:
Adapt Multimedia WORTH using a systematic adaptation framework; RA3. Evaluate feasibility, acceptability,
and preliminary effectiveness of the intervention through a randomized controlled trial (RCT) of 50 WICJ. Data
obtained from this K01 will support the NIDA priority focus area of addressing real world complexities of addiction,
by targeting barriers to treatment relating to gender, age, socioeconomic status, and race/ethnicity among
vulnerable WICJ. This K01 will provide Dr. Slavin training in: 1) adapting and implementing a culturally tailored
intervention, 2) conducting responsible research with vulnerable women, 3) utilizing a digital intervention to
address health disparities, and 4) quantitative and qualitative intervention evaluation research methodology.

Public health relevance
PROJECT NARRATIVE Women involved in criminal justice systems (WICJ), the majority of whom are reproductive-aged, have high rates of illicit substance use disorders (SUDs) and unmet contraceptive needs, (i.e., fecund, sexually active, and report not wanting more children or wanting to delay the next child, but are not using any method of contraception), leading to high rates of unintended pregnancies, and morbidity and mortality among women and their offspring. Culturally sensitive interventions that address barriers to substance use and sexual and reproductive health (SRH) treatment are lacking among WICJ, and evidence-based HIV-prevention interventions for WICJ who use drugs can provide a key platform for simultaneously addressing these needs. This proposed study will enable the candidate to identify and address key determinants of drug and contraceptive use among reproductive-aged WICJ to adapt a digital intervention (videoconference group-based treatment and digital interactive activities) with high capacity for real-world implementation and dissemination, to help reduce health disparities in SUD and SRH treatment among WICJ.